HYALURONIC ACID AND DERMATAN SULFATE IN AGING HUMAN SKIN

The effect of aging on the chemical and physical properties of hyaluronic acid and dermatan sulfate from human skin has not been studied. By using viscometry and discontinuous polyacrylamide gel electrophoresis, the mol. wt. of these molecules from the dermis of female fetuses, stillborns, 20-40 and 60-80 year olds will be determined. The non-reducing termini of hyaluronic acid will be studied with Beta-glucuronidase and Beta-N-acetylhexosaminidase; those of dermatan sulfate will be determined with the same exoglycosidases, plus Alpha-L-iduronidase. The polydispersities of hyaluronic and dermatan sulfate will be investigated by high pressure liquid or ion exchange chromatography. Dermatan sulfate from the same age groups will be analyzed for GlcUA/IdUA ratios, degree or sulfation, sulfate location and protein linkage. The protein that binds dermatan sulfate covalently will be isolated in 6M urea at 60 degrees C and characterized with respect to N-terminal and C-terminal amino acids, total carbohydrate and amino acid content, SH groups, disulfide bonds, and molecular weight. Antibodies to the dermatan sulfate-protein complex will be developed and used to study the association of dermatan sulfate with collagens (Type I, III, and IV) by immunoelectron microscopy. Dermal fibroblasts cultures will be established as a source of hyaluronic acid and dermatan sulfate, which will be analyzed as indicated above. The data obtained will elucidate: (a) the chemical and physical properties of hyaluronic acid and dermatan sulfate from female skin, (b) the role of these glycosaminoglycans in aging of the skin, (c) the nature of the dermatan sulfate-carrier protein, (d) association of dermatan sulfate with collagen (Type I, III, and IV) from newborns and adult dermis.